Research Services Core

PROJECT SUMMARY-RESEARCH SERVICES CORE. The goal of the Mississippi Center for Clinical and
Translational Research (MCCTR) Research Services Core (RSC) is to train and assist investigators in research
development and implementation including regulatory management, responsible conduct of research, effective
recruitment and retention, and research compliance. The RSC will provide a broad range of clinical,
epidemiologic, and population health expertise to investigators from the MCCTR Clinical and Translational
Research Scholars (CTRS) Program and Pilot Projects Program (PPP) to facilitate growth in clinical and
translational (C/T) and population health research with an emphasis on: racial/ethnic health disparities, rural
health, and telehealth. To facilitate implementation of C/T research to improve the lives of Mississippians, the
RSC will develop a new Telehealth subcore to reach rural areas of the state, which have high rates of
cardiometabolic diseases and worse health outcomes. In collaboration with the Community Engagement and
Outreach (CEO) Core, the RSC will also leverage new state networks including the Mississippi State Department
of Health and Mississippi State Extension Services to expand the reach of these important clinical programs.
During MCCTR Phase II, the RSC will expand use of electronic health data by partner institutions through greater
use of the UMMC Research Data Warehouse and Patient Cohort Explorer, which will allow investigators to use
“real world” data to explore a variety of health indicators and outcomes. The RSC will also facilitate broader early
career investigator involvement in large epidemiologic studies including the Jackson Heart Study, the
Atherosclerosis Risk in Communities (ARIC) Study, and the Risk Underlying Rural Areas Longitudinal (RURAL)
Study through creation of a new Cohort Study Navigator position. The RSC will work closely with all of the cores
but early interactions with the Biostatistics, Epidemiology, and Research Design (BERD) Core with each MCCTR
investigator will optimize chances of successful project design and completion. UMMC will serve as the “hub” for
clinical trials, and the RSC will expand use of the UMMC Clinical Research and Trials Unit through the RSC
Clinical Research Coordinators. The RSC will streamline the clinical trial process for MCCTR investigators and
assist with participant recruitment and retention of a diverse participant population by the partner institutions.
The RSC will also help expand collaborations between the MCCTR partner institutions as well as other
CTRs/CTSAs including the Mayo Clinic Center for Clinical and Translational Science (CCaTS), the University of
Alabama Birmingham Center for Clinical and Translational Science (UAB CCTS), the Louisiana Clinical and
Translational Science (LACaTS), and the Northwestern University Clinical and Translational Sciences Institute
(NUCATS). These collaborative networks will provide unique opportunities for larger scale investigations of
health disparities, rural health, and telehealth.